Structural and diffusion changes of perivascular space in aging, cognitive decline and Alzheimer's disease

PROJECT SUMMARY
Perivascular spaces (PVS) are the area around arterioles, venules and capillaries which accommodate the
clearance of the metabolic waste via Aquaporin-4 channels expressed on astrocytic endfeet and are involved in
blood-brain barrier transport. PVS have come to prominence recently through potential roles in brain interstitial
fluid drainage and waste clearance, and in the pathogenesis of Alzheimer’s disease (AD) and other
neurodegenerative disorders. While animal studies have precisely clarified this mechanism, data from humans
are relatively crude and limited to visual counting of visible PVS on clinical magnetic resonance images, and this
limits our understands of the morphology, biophysical properties and distribution of the PVS in human aging and
AD. The long-term goal is to understand the role of PVS in brain health and the degree to which it alters in AD.
The objective of this project is to map morphologic and diffusion characteristics of the PVS fluid in
healthy aging, and how it is altered in the early stages of AD. The central hypothesis is that imaging-derived
PVS fluid characteristics, such as volume occupied and diffusion properties, are differentially and selectively
altered in cognitive decline and AD in comparison with normal aging. The rationale underlying this proposal is
that in vivo noninvasive mapping of the PVS provides mechanistic insight about AD pathophysiology. The
proposed work will also develop widely applicable open resources to map PVS morphologic and diffusion
properties that can be applied to a wide range of neurological disorders. The central hypothesis will be tested by
pursuing three specific aims: 1) Characterize changes in PVS fluid in normal aging individuals with no cognitive
decline nor evidence of AD pathology and evaluate the effect of image acquisition strategy on outcome
measures; 2) Identify PVS alteration in cognitive decline and in individuals with AD pathology; and 3) Determine
the extent to which PVS is associated with cardiovascular risk factors versus AD pathology. We will pursue these
aims by applying innovative MRI-based computational techniques on recently available data of normal aging and
patients with cognitive decline from multiple large NIH-funded studies. Computational techniques include both
recently developed neuroimaging techniques sensitized to the PVS and more established structural image
analysis techniques. The proposed research is significant, because it will aid in the understanding of AD
pathophysiological mechanisms and consequently assist in the early diagnosis and disease monitoring of AD. It
is also significant because it will make public resources available that can be used to study other neurological
disorders characterized by impaired PVS in the brain. The results will have an important positive impact
immediately because they will identify and map, for the first time, PVS alteration in human brain across aging,
cognitively impaired and AD individuals. Our shared PVS imaging tools can also be more broadly applied to a
wide range of clinical and research applications by other groups as well.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because identifying pathological alterations to the brain glia- lymphatic pathway (i.e. perivascular spaces) is expected to aid in Alzheimer’s disease diagnosis and disease monitoring. It is also expected to fill the gap in knowledge regarding the role of the perivascular spaces in Alzheimer’s disease and its pathological neuroimaging signature. Thus, this proposal is relevant to the part of NIA's mission that pertains to fostering aging research and further characterizing the aging brain in Alzheimer’s disease.